MU PREP Scholars

PROJECT SUMMARY / ABSTRACT
The University of Missouri-Columbia (MU) proposes to identify, provide financial support, and train a total
of 35 students from groups dramatically underrepresented in the biomedical sciences in order to prepare
them to successfully enter and complete a PhD program in a biomedical or biomedical-related discipline
at MU or any other highly competitive research-intensive institution.
This proposal presents a coordinated plan to strengthen the research, academic, and personal
interaction skills of promising and talented baccalaureate graduates by immersing each Scholar in an
independent research project with a faculty mentor and providing a coordinated academic and personal
support system. Specific MU PREP components include design and completion of an independent
research project; strong research mentoring by committed faculty, aided by prior training of faculty
mentors; training in responsible conduct of research and scientific expression; training in critical thinking
and analysis; peer and group mentoring; and presentation of their research results at
national/international meetings in the discipline.
PREP Scholars should thus begin their PhD programs with advanced research skills, with a faculty and
peer mentoring system in place, with connections to a broader discipline beyond MU, and with lasting
friendships with other graduate students in the life sciences.
The MU PREP program will be carefully coordinated with MU's other undergraduate and PhD programs
for underrepresented students thereby advancing MU's comprehensive effort to increase the number of
scholars from underrepresented populations in the biomedical sciences.
Successful parts of this program will be institutionalized and disseminated as a model for other
institutions.

Public health relevance
PROJECT NARRATIVE The MU PREP, because of the departments and faculty research mentors involved, will have a natural focus on research training in areas that will address major health problems in the U.S. (e.g., cancer, cardiovascular disease, diabetes, and obesity). Of particular interest are health problems that disproportionately affect portions of the U.S. population. This will hopefully lead to greater interest in and research on those health problems at MU, and to a larger number of biomedical researchers working on those problems when our PREP Scholars, and the colleagues they influence, join the biomedical workforce.